UCSF Type 1 Diabetes Research Center

Overall Summary
The University of California at San Francisco Diabetes Research Center (DRC) will function as a basic and
clinical research enterprise at the forefront of type 1 diabetes (T1D) research. The DRC crosses the
boundaries of Departments and Schools to support a highly interactive team investigating all forms of diabetes
to advance the understanding and treatment of the disease. The DRC integrates the research activities of the
UCSF Diabetes Center, the administrative home of the DRC, with a broad range of diabetes-related research
throughout UCSF. The combined intellectual and research expertise of the DRC encompasses 43 diabetes
investigators from UCSF, UC Berkeley, and UC Davis, focused on both basic and clinical research, supported
with $22M in annual direct costs in diabetes-related grant funding, including $12M in Federal funding.
In this application, we propose to continue the success of the UCSF DRC in promoting, enhancing and
integrating T1D research at UCSF. That goal is realized through support for the following activities:
Administrative Core provides leadership, infrastructure, administrative support, advice and oversight to the
other components and members of the DRC; regularly adapts Cores and programs to fit the needs of the
members; and interfaces with the NIDDK, other NIH Diabetes Centers, and the lay community.
Enrichment Program organized by the Administrative Core supports DRC members and the regional diabetes
research community by enhancing scientific exchange and training with seminar series, invited speakers,
and an annual retreat.
Biomedical Medical Research Cores
Islet Core: Provides mouse and human islets and technologies for working with those islets, together with
expertise, advice and training.
Flow and Mass Cytometry Core: Provides equipment, assistance and training for human and animal cell
analyses.
Microscopy Core: Provides advanced imaging equipment, technologies, advice and training.
Pilot & Feasibility Program funding small innovative projects that support new investigators, attract new
investigators to diabetes and the DRC, explore new questions by established investigators, and promotes
interactions and collaborations leading to new external funding support to further goals of the DRC.

Public health relevance
Project Narrative: The Diabetes Research Center (DRC) provides an Administrative Core, Enrichment Program, Biomedical Cores and a Pilot and Feasibility grant program to support a highly interactive team investigating type 1 diabetes to advance the understanding and treatment of the disease.